MECHANISMS OF ANTIARRHYTHMIC DRUG ACTION SUPPLEMENT--SIMULATED MICROGRAVITY

To quantify the effect of a 50% reduction of sympathetic activity produced by guanadrel and simulated microgravity taking advantage of state of the science techniques including measurements of norepinephrine spillover and clearance and direct measurements of sympathetic nerve traffic with microneurography. To evaluate whether a different model of weightlessness using guanadrel mimics the biochemical and physiological alterations characteristic of microgravity environment.